Cell-Free DNA Methylation Patterns as a Biomarker for Tumor Biology and Clinical Outcomes for Glioblastoma Patients

ABSTRACT
Glioblastoma is a uniformly lethal brain tumor despite aggressive and toxic standard of care treatments including
surgery, radiation, and chemotherapy. One of the main barriers to understanding glioblastoma tumor biology and
developing more effective therapies is the dependence on invasive surgical procedures for diagnosis. The need
to obtain tumor tissue for initial diagnosis in patients with glioblastoma is limited by 1) intratumoral heterogeneity
(genomic and epigenomic), 2) temporal heterogeneity, 3) sampling error, and 4) surgical eligibility. Additionally,
surveillance of glioblastoma remains a diagnostic challenge since recurrent disease is often indistinguishable
from treatment-induced inflammation, termed pseudoprogression, on conventional imaging, which contributes to
diagnostic ambiguity and treatment delays. The identification of a non-invasive, prognostic biomarker for
longitudinal molecular profiling of glioblastoma could overcome these challenges, improving risk stratification,
clinical trial design, surveillance, and standard of care. Our prior work revealed that changes in peripheral
immune cell populations from whole-blood samples of patients with primary and recurrent glioblastoma correlate
with treatment response and overall survival, thus supporting the concept of a local and systemic tumor
microenvironment. In non-CNS tumors, circulating tumor DNA (ctDNA) has received considerable attention to
assess tumor burden, predict treatment response, and select therapies. However, classical ctDNA approaches
using somatic mutation analysis are limited in glioblastoma due to the lack of recurrent somatic mutations,
significant intertumoral heterogeneity, and low detectability of somatic mutations in blood. We hypothesize that
methylation profiling of cell-free DNA (cfDNA) can overcome these limitations, as epigenetic modifications are
detectable in cfDNA, correspond to the cell of origin and cell state, are stable and detectable with a low input of
genomic DNA (<250 ng), and offer a greater breadth of information about the state of the cell of origin and
differential responses of clonal lineages to treatment. To our knowledge, cfDNA methylation has not been
evaluated in a prospective clinical trial as a biomarker for brain tumor biology or correlated with clinical outcomes.
To test this hypothesis, we will employ prospective blood sample from patients with glioblastoma enrolled in the
completed randomized Phase II VERTU trial (NCT02152982) to determine whether cfDNA methylation patterns
cluster with specific tumor tissue DNA methylation patterns (Aim 1). We will then characterize the impact of
changes in cfDNA methylation patterns on clinical outcomes, including survival (Aim 2). Finally, we will evaluate
whether the activation state of circulating immune cell populations, inferred from cfDNA methylation patterns,
can be used to non-invasively distinguish pseudoprogression from recurrent disease (Aim 3). These translational
aims have the potential to guide the development of non-invasive diagnostic and surveillance platforms for
patients with glioblastoma, which could impact treatment selection and clinical trial design.

Public health relevance
NARRATIVE Glioblastoma is the most common primary malignant brain tumor in adults and remains fatal despite aggressive treatments. One of the main barriers to understanding glioblastoma tumor biology and developing more effective therapies is the dependence on tumor tissue obtained via invasive surgical procedures for diagnosis. This work will evaluate whether cell-free DNA methylation patterns derived from peripheral blood correlate with tumor biology and treatment response, thereby providing a method for longitudinal molecular profiling.